Function and regulation of constitutive protein translation in platelets

Project Summary
The goals of this proposal are: 1) to elucidate the molecular signaling of protein translation initiation in
circulating human platelets and characterize the plasma growth factor- or hormone-driven pathways, map the
regenerating human platelet proteome, and determine the roles of constitutive translation in platelet functional
reactivity; 2) to determine the roles of ARGONAUTE2 (AGO2, Ago2 in mice) in platelet mRNA, microRNA
(miRNA) and protein expression, platelet reactivity, and the specific roles of platelet miRNA-mediated
suppression of translation in hemostasis and thrombotic potential. The studies in this proposal will elucidate
essential concepts of the molecular physiology of platelet function. In addition, these studies will have profound
implications for two areas of widespread clinical significance: alterations in growth factor/hormone
homeostasis, and current use and development of pharmacological inhibitors of translation in disease
treatment. Surprisingly little attention has been paid to roles of translation in so-called “resting” platelets in
circulation, following the overall presumption that translation is of limited importance. In prior studies of
“resting” platelet translation, ex vivo platelets were removed from their native plasma environment, and
translation steadily came to a halt. We interpret these prior studies to suggest instead that platelets undergo
translation constitutively in the presence of plasma, e.g., in circulation, and that this expenditure of molecular
resources and cellular energetics is critical for platelet protein homeostasis and functionality. Our strong
preliminary data support this hypothesis and we propose a series of innovative approaches to investigate this
poorly understood aspect of platelet biology and its functional outcomes. We have shown for the first time that
platelets in circulation undergo constitutive translation of a robust proteome due to translation initiation
signaling driven by plasma-borne growth factors and hormones, that this process is modulated by platelet
miRNAs and AGO2, and that constitutive miRNA-modulated translation in platelets regulates platelet function.
We will pursue an array of innovative approaches to test the following hypotheses: Aim 1- 1) “resting” platelets
in circulation are translationally active due to ongoing signaling initiated by plasma growth factors and
hormones; 2) constitutive translation driven by plasma growth factors maintains platelet protein homeostasis
necessary for hemostatic function; Aim 2 - 1) abundant miRNAs and Ago2-mediated RNA inhibition in platelets
modulate constitutive translation driven by plasma growth factors and hormones; 2) Ago2/miRNA-mediated
suppression maintains platelets in a reactive state necessary to support hemostasis while limiting thrombosis.
Together, the outcomes of these studies will significantly expand our understanding of control of platelet
function, hemostasis and thrombosis, as well as implications for platelet reactivity and function in growth factor
or hormone imbalance in disease, and potential impacts of clinical translation inhibitors on these processes.

Public health relevance
Project Narrative Platelets are small cells that circulate in blood for about ten days, and their primary function is to initiate and promote hemostasis – clot formation at a site of blood vessel injury to prevent blood loss which requires rapid activation of platelet molecular and cellular responses to drive clotting; conversely, platelet hyper- reactivity creates a pro-thrombotic state with increased risk of blood clots that can block vessels, a major clinical concern. Therefore, control of platelet activity is a high impact research goal broadly affecting many disease states as well as aging; however, thorough understanding of the molecular and cellular mechanisms that regulate platelet reactivity remains incomplete. In this study we will investigate new molecular regulators of platelet reactivity in healthy plasma we have identified and begun to characterize, which affect specific but poorly understood platelet responses, including their mechanisms of action, roles in platelet functional response, and contributions to hemostasis and thrombotic potential, with broad implications across the spectrum of clinical management of bleeding and clotting.